DataJoint SciOps: A Managed Service for Neuroscience Data Workflows

Project summary
This SBIR proposal aims to address current challenges in data-driven neuroscience by implementing DataJoint
SciOps: a commercial service to help research labs implement computational workﬂows for data-intensive science
experiments. This turn-key service will organize secure data pipelines and automate analysis jobs based on scalable
cloud infrastructure while keeping the entire process transparent and reproducible. Progress in neuroscience relies
on analyzing vast amounts of complex data recorded by new generations of neurotechnologies. To analyze this data,
research teams develop advanced algorithms and share them as open-source software. These software toolchains
require advanced computing infrastructure and operations, posing a set of engineering hurdles to manage the
particular experiment workﬂows for data entry, acquisition, analysis, sharing, and publishing. DataJoint SciOps
is made possible by the DataJoint Elements program (NIH Grant U24 NS116470), which provides a collection of
community-curated software modules for building standardized computational workﬂows. These designs integrate
best-in-class open-source analysis software from leading research teams and provide integrations with neuroscience
infrastructure projects. DataJoint SciOps will effectively serve as the commercial extension of DataJoint Elements
by providing computing infrastructure, hosting, and a managed service with subject-matter expert support and
customization services.
This Direct-to-Phase II commercialization project will develop and validate a comprehensive managed service for
executing data-centric neuroscience projects with robust automated processes for data management and analysis
(Aim 1). A cloud-based software-as-a-service platform will streamline the service to enable scaling to hundreds of
labs through standardization, self-service, and process automation (Aim 2). In the process, DataJoint will partner
with Johns Hopkins University's Applied Physics Lab to integrate the platform with neuroinformatics resources and
provide collaboration interfaces (Aim 3). Jointly, the teams will ensure the transparency and reproducibility of the
managed workﬂows and integrate it with other data infrastructure programs in the U.S. and internationally.
With several thousand neuroscience research groups seeking to adopt advanced neurotechnology instruments and
analysis tools, the commercially operated DataJoint SciOps service will lower the technological and organizational
barriers for efﬁcient and reproducible research.
1

Public health relevance
Project narrative The project will commercialize a managed service for collecting, analyzing and sharing large-scale neurophysiology data. The solution will provision on-demand computational infrastructure and automate processes for recordings in studies of brain function in health and disease. The project will foster open science and reproducible research and will facilitate access to high-performance computing for a diverse population of academic and scientiﬁc projects in the U.S. and globally. 2